Urocortin 2 Gene Transfer for Heart Failure with Preserved Ejection Fraction

This proposal focuses on development of a new treatment for patients with heart failure and preserved
ejection fraction (HFpEF). Among symptomatic patients with HF, half have HFpEF, and their mortality is
similar to those with HFrEF. However, there are currently no treatments for HFpEF that prolong life, and
few (if any) that reliably reduce HF hospitalization rates. We need new therapies to address this unmet
medical need. Cardiovascular gene transfer is conceptually an attractive method for treating HF, but
difficulty in obtaining high yield transgene expression in the heart in a manner that can be easily and safely
applied has been challenging. However, we recently have demonstrated the effectiveness of intravenous
(i.v.) delivery of a long-term expression vector (AAV8) encoding a peptide, urocortin 2 (Ucn2), which
possesses favorable cardiovascular effects through its paracrine/endocrine actions. In our current VA Merit
grant we have established the safety and efficacy of a 1-time i.v. administration of AAV8.Ucn2 in two
murine models of HFpEF—aging and pressure overload, two risk factors for clinical HFpEF. However,
there are several important issues that must be resolved prior to clinical translation of this much-needed
therapy.
Hypothesis: Ucn2/Ucn3 gene transfer, through paracrine/endocrine effects, will improve cardiac function
and survival in two models of HFpEF (in different species) via corticotropin releasing hormone
receptor 2 (CRHR2)-dependent enhancement of Ca2+ handling in cardiac myocytes
Aim 1: To determine the effectiveness and survival advantage of Ucn2 vs Ucn3 gene transfer in a model
of HFpEF due to hypertension (Dahl Salt-Sensitive Rat)
Aim 2a: To determine if the beneficial effects of Ucn2 gene transfer on LV function in aged mice are
abrogated by cardiac-targeted deletion of CRHR2
Aim 2b: To determine whether the beneficial effects of Ucn2 gene transfer on the aged LV result from
enhanced Ca2+ handling and increased rates of sarcomere shortening and lengthening
Aim 3: To determine the intracellular mechanisms linking Ucn2 and Ucn3 peptide activation of CRHR2
with enhanced Ca2+ handling in cultured cardiac myocytes
These Aims are designed to answer key questions: 1) Will the benefits of Ucn2 gene transfer be seen in a
second species in a second model of HFpEF (hypertensive Dahl Salt-Sensitive rats), will it confer a survival
advantage, and will Ucn3 gene transfer have similar beneficial effects? These questions will be addressed
in Aim 1; 2) To what degree are the beneficial effects of Ucn2 gene transfer due to cardiac CRHR2
activation vs systemic vasodilation due to activation of CRHR2 in smooth muscle and attendant systemic
vasodilation? We will address this question by using cardiac-targeted deletion of CRHR2 (Aim 2);
3) Finally, we propose to map the intracellular pathways (mechanisms) from CM CRHR2 stimulation by
Ucn2/Ucn3 to the predicted increase in Ca2+ handling in a series of studies conducted in isolated CMs
(Aim 3). These preclinical studies, which are focused on mechanism of action and effectiveness of
treatment in vivo will serve as a segue for an additional study in a large mammalian model of HFpEF under
separate funding, and subsequently to the filing of an IND application for the initiation of a clinical trial, a
transition we have made in our laboratory twice previously (ClinicalTrials.gov: NCT00787059 and
NCT00346437).

Public health relevance
Six million people in the US have heart failure and 550,000 new cases are diagnosed annually. Despite current optimal therapy, there are 300,000 deaths every year in the US due to heart failure. Among these 6 million patients, 3 million have heart failure with normal ejection fraction, a measure of the heart’s ability to pump blood. However, conventional therapies, which have been shown to reduce mortality in patients with heart failure with reduced ejection fraction, fail to reduce mortality in patients with heart failure with normal ejection fraction. Because the prevalence of heart failure with normal ejection fraction is increasing, and outlook is dismal, we need new treatments. We propose, based on studies performed in the previous tenure of our VA Merit award, that intravenous delivery of a virus vector encoding the protein urocortin 2 is a promising approach for these patients. The proposed work will test this in rat and mouse models of heart failure with normal ejectionfraction, determine mechanisms, and test related proteins such as urocortin 3.